SUPPORT FOR THE NIH SBIR/STTR APPLICANT ASSISTANCE PROGRAM (AAP) IN SUPPORT OF THE DEPARTMENT OF HEALTH AND HUMAN SERVICES, NATIONAL INSTITUTES OF HEALTH (NIH), NATIONAL CANCER INSTITUTE (NCI), SMALL

This contract supports SBIR Applicant Assistance Program.